MADRE (Mammograms Available Due to Research and Education)

There are populations at risk for late stage breast cancer (BC) diagnoses and worse post-diagnosis
quality of life, including Latinas, in part due to non-adherence to guideline-concordant screening.
Education+navigation (educate) approaches offer community education to address psychosocial
barriers (e.g., fear) and navigate individuals to free/low-cost breast cancer care. Our transdisciplinary
team has developed a promising empowerment+navigation (empower) approach that may lead to
greater BC screening. In the empower approach, individuals who are non-adherent to US Preventive
Services Task Force (USPSTF) guidelines learn about BC; are navigated to free/low cost breast
cancer care; and gain communication skills to promote BC screening throughout their networks. Our
premise is that empowering non-adherent individuals as breast health agents may lead to
greater BC screening among non-adherent individuals and their networks than treating non-adherent
individuals as passive recipients of education. The current proposal tests our premise and identifies
“active ingredients” of the empower approach. In Aim 1, we will conduct an individual randomized
controlled trial (RCT). Among non-adherent individuals, we will compare the effects of empower and
educate approaches on initial and repeat BC screening, in line with USPSTF guidelines. In Aim 2, we
conduct an observational social network study. We will recruit network members through nonadherent
individuals enrolled in our RCT. Among network members, we will compare the effects of
empower and educate approaches on initial and repeat BC screening across four years. In Aim 3, we
will explore theoretical mechanisms of change that could contribute to intervention differences in BC
screening. For non-adherent individuals’ BC screening, we will examine the mediating roles of greater
BC knowledge and motivation to be healthy role model. For network members’ BC screening, we will
examine the mediating role of non-adherent individuals’ enhanced capacity to promote BC screening.
Specifically, we will test the independent effects of volunteerism in community BC initiatives, potential
to “bridge” network members with formal change agents (e.g., community health workers, navigators),
acceptability to promote BC, feasibility to promote BC, and BC promotion to network members. Our
innovative, robust approach has direct implications for expediting the translation of promising
community interventions into practice.

Public health relevance
The goal of this proposal is to improve the guideline-concordant breast cancer (BC) screening in Chicago, by testing a new empowerment (empower) approach - wherein non-adherent individuals are empowered to become informal breast health leaders in their community and are navigated to affordable, accessible care. We will examine if, relative to traditional approaches, the empower approach leads to greater BC screening among non-adherent individuals and others in their social networks. We will also explore and identify the “active ingredients” that lead to greater BC screening in the empower approach - including greater knowledge, motivation to be a healthy role model, volunteerism in community BC initiatives, potential to “bridge” network members with formal change agents (e.g., community health workers, navigators), acceptability to promote BC, feasibility to promote BC, and BC promotion to network members.